Innate Immunity in NASH

Nonalcoholic steatohepatitis (NASH), a cell death and inflammation-associated nonalcoholic fatty liver disease
(NAFLD), is the leading cause of hepatocellular carcinoma (HCC) and end-stage liver failure worldwide. There is
no effective therapeutic drug for NASH to date, highlighting an urgent need for the identification of novel targets
for this devastating disease. Evidence cumulated over the past decade strongly suggest that the innate immune
system, specifically the liver-resident macrophages (Kupffer cells) and recruited monocyte-derived
macrophages, play a key role in NASH progression and pathogenesis. The current study aims to elucidate the
mechanisms by which macrophage cyclic GMP-AMP synthase (cGAS)-stimulator of interferon genes (STING)
pathway regulates liver fibrosis and NASH pathogenesis. We found that macrophage-specific knockout of cGAS
or STING promotes liver inflammation, apoptosis, and fibrosis, suggesting this DNA sensing innate immune
pathway protects, rather than promotes, NASH progression in mice. However, how cGAS or STING deficiency
leads to NASH pathogenesis remains unknown. Our preliminary study suggests that macrophage cGAS may
suppress NASH development by facilitating macrophage phagocytosis via both STING-dependent and
independent novel mechanisms. To test this hypothesis, we will 1) delineate the STING-independent molecular
mechanism by which cGAS promotes macrophages phagocytosis; 2) Elucidate the STING-dependent signaling
mechanism by which cGAS regulates macrophage phagocytosis; and 3) Explore the physiological role of
cGAS-regulated phagocytosis in preventing liver fibrosis and NASH. Our study will dissect a novel role
mechanism by which cGAS regulates macrophage phagocytosis and prevents NASH. The comprehensive
understanding of the fundamental functions of the innate immunity and macrophage biology will not only provide
a proof-of-concept for rethinking the nature of this devastating liver disease, but also open a new therapeutic
avenue for developing therapeutic treatment of NASH.

Public health relevance
Epidemiological studies identify that nonalcoholic steatohepatitis (NASH), a cell death and inflammation- associated nonalcoholic fatty liver disease (NAFLD), is the leading cause of hepatocellular carcinoma (HCC) and end-stage liver failure worldwide. The goal of this study is to investigate the role of the innate immune sensor cGAMP synthase (cGAS) in limiting tissue injury, improving tissue microenvironment homeostasis, and thus preventing nonalcoholic steatohepatitis. Identification of new drug targets and elucidating their mechanisms of action are critical for developing effective therapeutic treatment for liver metabolic diseases.